Functions of BRD8 in HR+/HER2+ breast cancer

PROJECT SUMMARY
The outcome for patients with HER2-positive breast cancer (BC) has been significantly improved with the
use of HER2-directed agents; however, hormone receptor (HR)+/HER2+ BCs that express both HR and
HER2 are less responsive to anti-HER2 therapies as compared with HR-/HER2+ BC. Combined endocrine
therapy plus anti-HER2-targeted therapy have been clinically investigated, but only a small subset of
patients benefit from the treatment, indicating that HR+/HER2+ tumors have different biological
characteristics, such as ER and HER2 signaling crosstalk. Dual HER2-blockade induces a Luminal A-like
phenotype both in patients’ tumors and in in vitro models. However, the molecular mechanism underlying
activation of ER signaling by anti-HER2 agents remains unclear. Using single cell RNA-sequencing
(scRNA-seq), we identified Bromodomain Containing Protein 8 (BRD8) as an essential hub bridging HER2
and ER signaling pathways. We found that, BRD8, a component of p400 histone acetylase complex, was
rapidly induced by treatment with a variety of anti-HER2 agents including neratinib, lapatinib and
trastuzumab and that BRD8 is at the high hierarchy of ER activation in responsive to HER2 blockade.
Furthermore, BRD8 regulates other growth promoting pathways in addition to ER. BRD8 knockout
significantly impairs growth of a fulvestrant-resistant cell line and xenografts, and BRD8 knockdown
enhances the sensitivity of HR+/HER2+ cells to HER2-targeting agents. These preliminary data lead to the
hypothesis that BRD8 is an essential hub linking ER and HER2 pathways and BRD8 mediates ER
activation in response to HER2 blockade in HER2+ cells. Therefore, combinatory BRD8 ablation with HER2
blockade should be effective for treating HR+/HER2+ BC. We propose three aims to test our hypothesis: (1)
to elucidate the mechanism of BRD8 activation by anti-HER2 agents in HER2+ cells at the single cell level;
(2) to define the roles of BRD8 in ER signaling activation and ER-independent functions upon HER2
blockade; (3) to test whether ablation of BRD8 sensitizes HR+/HER2+ BC to anti-HER2 blockade. The
studies will reveal, at single-cell level, the cell-cell variability of BRD8 induction by anti-HER2 agents, and
the novel functions of BRD8 in mediating ER/HER2 signaling crosstalk and ER-independent growth
promoting functions. The mechanistic insights will lay foundation for developing combinatory BRD8 ablation
and HER2 blockade therapy as a new treatment regimen for HR+/HER2+ BC.

Public health relevance
PROJECT NARRATIVE ER+/HER2+ breast cancer comprises ∼13% of all breast cancer, with intensive crosstalk between ER and HER2 signaling. Various combinations of endocrine and anti-HER2 targeted agents are under clinical evaluation, yet only a partial response has been achieved. This proposal seeks to identify mechanisms of ER/HER2 crosstalk at the single-cell level that accounts for the partial response of ER+/HER2+ patients to dual ER/HER2 blockade.